Strategies to Innovate EmeRgENcy Care Clinical trials Network (SIREN) Network - Pittsburgh

The University of Pittsburgh site for the Strategies to Innovate Emergency Care Clinical Trials Network (SIREN) will continue its leadership as a Hub for recruiting participants into emergency care research. Advancements in acute treatment for time-sensitive and life-threatening conditions requires high quality and rigorous trials. The unexpected nature of emergency conditions sometimes demands that participants enter trials under atypical processes such as an Exception from Informed Consent. Emergency care spans multiple locations including prehospital, emergency department, intensive care unit, and home. An experienced research team will implement pragmatic and successful strategies to accomplish enrollment under all these conditions and in all these settings at multiple sites by addressing the following Aims. 1. Provide administrative structure to rapidly implement and enroll from multiple sites in multiple clinical trials of emergency treatments. 2. Explore strategies to increase recruitment, and consent in emergency treatment trials. 3. Explore strategies to increase quality of emergency care data and to ensure retention of subjects enrolled in emergency settings. 4. Advance participation and training for early career investigators.

Public health relevance
Rigorous clinical trials are necessary to improve acute treatment for time-sensitive and life-threatening conditions. The unexpected nature of emergency conditions requires special preparation and skill to recruit and protect participants in clinical trials. Emergency care spans multiple locations including ambulances, emergency departments, intensive care units, and even homes. An experienced research team will implement pragmatic and successful strategies to accomplish enrollment under all these conditions and in all these settings at multiple locations as part of a national emergency care research network.